Cultural adaptation and feasibility testing of a technology-based pediatric weigh management intervention for rural Latino communities

Addressing childhood obesity risk factors like home environment, parental roles, excess weight, physical
activity, and healthy eating among Latinos/Hispanic (L/H) families living in rural communities is an
important priority. Among Latinos/Hispanics--the fastest growing population in United States—childhood
obesity is rising. An effective strategy for controlling childhood obesity growth is family-based programs
targeting the parents of overweight and obese children. However, evidence supporting these interventions
among L/H families living in rural communities is missing. Here we will use cultural adaptation and
implementation science frameworks to evaluate the feasibility of delivering a culturally appropriate familybased
childhood obesity (FBCO) program via an automated telephone system (IVR) to L/H families living in
rural Nebraska. We will conduct a mixed-methods feasibility trial for L/H families with overweight or obese
children. In Aim 1, we will first collaboratively adapt all intervention materials to better fit the rural L/H
community profile, including translation of materials to Spanish, inclusion of culturally relevant content and
images, and use of health communication strategies to address different levels of health literacy. Then, we
will evaluate the cultural relevance, suitability, and usability of the adapted intervention materials and mode
of delivery. In Aim 2, we will randomly assign participant dyads (parent and child) to either Family
Connections (n=29) or an enhanced standard-care group (n=29) and determine overall study reach,
preliminary effectiveness in reducing child BMI z- scores, potential for program adoption, implementation,
and sustainability through local health departments (RE-AIM outcomes). We will also evaluate health
department perceptions of i-PARIHS constructs (innovation, context, recipient characteristics), and Family
Connections participants’ view of the intervention (i.e., relative advantage, observability, trialability,
complexity, compatibility). In conclusion, the study will answer three important questions: (1) Is a telephone
delivered FBCO program in rural Nebraska culturally relevant, usable and acceptable by L/H families?
(2) Is a telephone delivered FBCO program effective at reducing BMI z-scores in L/H children living in rural
Nebraska? and (3) What real-world institutional and contextual factors influence the impact of the
intervention and might affect its potential ability to sustainably engage a meaningful population of L/H
families who stand to benefit? This project will generate locally and globally relevant evidence on a
culturally appropriate technology-delivered FBCO intervention for L/H families in rural communities.

Public health relevance
The prevalence of childhood obesity in Latino/Hispanic children is 60% higher than that of non-Latino/Hispanic whites in the US. Family-based childhood obesity (FBCO) interventions targeting parents have shown promising results for reducing weight among children but fail to reach a large and representative sample of rural Latino/Hispanics and show no evidence of being sustained in typical clinical or rural community practice. Technology-delivered FBCO programs show promise in addressing these challenges by providing culturally tailored content and allowing rural Latino/Hispanic families to take part in the program when and where they choose it.